Investigating the role of RNA helicase DHX36 in modulating aberrant RNA condensation

Project Summary
Stress granules (SGs) are transient cytoplasmic ribonucleoprotein (RNP) granules formed in
response to cellular stress. SGs play crucial roles in regulating RNA metabolism and promoting
cell survival, but their persistence can be cytotoxic and contribute to neurodegenerative diseases.
Stable RNA G-quadruplex structures (rGQs) are involved in SG formation and can inﬂuence their
biophysical properties to form either liquid- or solid-like assemblies. Hence, aberrant
accumulation of rGQs can compromise SG dissolution upon removing stress, resulting in SG
persistence. The primary focus of this application is to investigate how the RNA helicase DHX36,
known for its ability to remodel rGQs, inﬂuences SG dissolution and aging dynamics.
The proposal is structured around three speciﬁc aims. Aim 1 will examine how altering DHX36
levels and perturbing its ATP/RNA binding ability aﬀects SG aging dynamics, with a hypothesis
that DHX36-mediated remodeling of rGQs in SGs is necessary for maintaining the ﬂuidity of SGs
and preventing their transition to solid-like, potentially harmful states. Using live-cell imaging
and quantitative biophysical methods, we will track SG disassembly kinetics following stress
exposure and DHX36 manipulation. Aim 2 focuses on understanding how DHX36 aﬀects SG
biophysical properties and aging dynamics, by employing optical tweezer-based nano-rheology
approaches in an in vitro lysate-based stress granule system. Aim 3 will assess DHX36’s ability to
remodel aberrant RNA condensation, particularly in the context of neurological diseases such as
ALS, where repeat expansion RNAs form toxic condensates. Using bottom-up reconstitution of
RNP condensates, this aim will test a hypothesis that DHX36 can chaperone intra-condensate
liquid-to-solid phase transitions of repeat RNAs.
By combining innovative biochemical, biophysical, and live-cell imaging approaches, this
research aims to provide novel insights into the cellular mechanisms that regulate SG dynamics
and RNA condensation. The ﬁndings could have broad implications for understanding RNP
granule aging and may lead to potential therapeutic strategies for neurodegenerative disorders
associated with aberrant RNP granules. The fellowship will be conducted at the University of
Buﬀalo in the laboratory of Dr. Priya Banerjee, a leading researcher in the biophysics and biology
of RNA-protein phase separation. This environment provides access to cutting-edge biophysical
tools and a collaborative, interdisciplinary training environment, ensuring comprehensive
preparation for an independent research career.

Public health relevance
Project Narrative This proposal aims to investigate the mechanistic role of RNA chaperone DHX36 in modulating the formation, properties, and aging of RNA−protein (RNP) granules that are essential for cell survival under adverse stress conditions. The findings are expected to provide new insights into the cellular mechanism of RNP granule aging and may lead to potential therapeutic strategies for neurodegenerative disorders associated with aberrant stress granules.